Allergen Exposure Reduction as a Disease-Modifying Strategy in Allergen-Sensitized Children with Asthma

PROJECT ABSTRACT/SUMMARY:
Torie Grant, MD, MHS is an Assistant Professor of Pediatrics and Medicine at Johns Hopkins University
School of Medicine. Dr. Grant seeks a K23 Mentored Patient-Oriented Research Career Development Award
in order to obtain the skills, knowledge, and mentored research experience that are the essential foundation for
a career as an independent clinical investigator studying pediatric determinants of adult lung disease. Dr.
Grant's career development plan includes the pursuit of a PhD in epidemiology at the Johns Hopkins
Bloomberg School of Public Health. Her mentorship team includes established physician scientists with
decades of research and mentorship experience: Dr. Robert Wood (co-primary mentor) has over 30 years of
pediatric asthma research and mentoring experience; Dr. Elizabeth Matsui (co-primary mentor) has been the
PI of multiple pediatric asthma studies focusing on environmental exposures; Dr. Robert Wise is an expert in
pulmonary function testing and asthma clinical trialist; Dr. Corinne Keet is an expert is asthma epidemiology
and environmental risks for asthma and allergic diseases; Dr. Allen Everett is an expert in biomarker discovery;
and Dr. Roger Peng is an environmental biostatistician with expertise in environmental exposures and health
outcomes.
Current pediatric asthma therapies are effective in achieving asthma control, but have little effect on the
progression of asthma into adulthood. Emerging evidence suggests that indoor allergen exposure may have
deleterious effects on lung function trajectory from childhood to adulthood among allergen-sensitized children
with asthma. Aim 1 of this proposal seeks to examine the long-term effects of indoor allergen exposure and
sensitization on lung function growth and risk of adult obstructive lung disease. Aim 2 will examine the effects
of indoor allergen exposure reduction on lung function growth. Aim 3 will explore the relationship between
indoor allergen exposure reduction and hypothesis-driven biomarkers of pulmonary fibrosis and remodeling.
These aims will add critical knowledge to our understanding of the role of indoor allergen exposure in lung
function growth, conceptualizing allergen reduction as a disease-modifying therapy. Dr. Grant's background as
an internist, pediatrician, and allergist-immunologist, with training in epidemiology and biostatistics, makes her
the ideal candidate to study adult lung function outcomes in pediatric asthma.

Public health relevance
PROJECT NARRATIVE Children with asthma are at risk for abnormal lung function growth, lower lung function in adulthood, and adult obstructive lung disease, which are associated with increased mortality risk. The project will examine the effects of indoor allergen exposure and allergen reduction on long-term lung function growth and explore their effects on biomarkers of pulmonary fibrosis and remodeling. This work is designed to test the hypothesis that allergen exposure reduction improves lung function trajectory among children with allergic asthma, which, if true, would have a major public health impact.